Ex Vivo Storage, Preservation And Rehabilitation Of Living Heart Valves For Allogenic Valve Transplantation

There is an urgent need for cardiac valve replacements capable of growth and self-repair for children with
congenital valve disease, for whom the current standard of care is multiple open-heart surgeries to repair or
replace structurally-degraded valve prostheses. Living allogenic valve transplantation (LAVT) has recently
emerged as a means of delivering valve replacements capable of achieving these goals. However, there are key
limitations: (i) restricted availability, (ii) limited ex vivo viability, (iii) the cost, time and resource constraints related
to minimizing tissue ischemic time, and (iv) immunogenicity. There is an urgent clinical need to develop methods
for storing and preserving living valvular allografts ex vivo, that remain viable and available off-the-shelf for
implantation. Our central hypothesis is that integrating a preservation solution which supports interstitial cell
metabolic activity with biomimetic mechanical stimulation will maintain valvular viability and growth-capacity for
at least 6 weeks ex vivo, while reducing immunogenicity. The rationale is that extending the ex vivo viability of
valvular tissue would significantly improve the availability, cost-effectiveness, logistics and widespread clinical
adoption of LAVT. First, a biomimetic strategy for the extended storage, preservation and rehabilitation of living
valvular allografts will be validated (Aim 1). Tissue preservation over 8 weeks of storage will be evaluated via
a multi-scale approach, from the macrostructure to resident cell phenotype. Anticipated outcomes include (i) a
preservation solution for valvular tissue, and (ii) a custom bioreactor for long-term storage, which continuously
exposes valves to physiologic open/close cycles and transvalvular pressure gradients in a sterile, low-cost
fashion. Second, we will evaluate the impact of the storage and rehabilitation strategy on the allograft's capacity
for growth and self-repair in a growing piglet model (Aim 2). We anticipate that stored valves will demonstrate
growth and self-repair capacity non-inferior to that of freshly transplanted valves and superior to cryopreserved
ones. Third, we will characterize the effect of IL-10 and storage time on the allogeneic immune response to
valvular allografts in vitro and in vivo (Aim 3). Outcomes evaluate the host immune response to valvular
transplants in a large animal model with or without immunosuppression, while simultaneously evaluating whether
the risk of an adverse immune response can be mitigated through immunomodulation. The project's success
would enable off-the-shelf availability of living allogenic valves, significantly enhancing the spatiotemporal
availability and logistic-ease of LAVT. Understanding the allogeneic immune response to valvular allografts will
inform clinical immunosuppression protocols, as well as techniques for immunomodulation of valve tissue.
Altogether, this innovative approach to living valve storage is paradigm-changing, offering patients the first-ever
off-the-shelf available living valve replacement option capable of somatic growth and self-repair, which can act
as a life-lasting valve. This work will be carried out by an multidisciplinary team which is uniquely poised for
success with an established history of collaboration synergizing translational research with clinical experience.

Public health relevance
PROJECT NARRATIVE There is an urgent need for valve replacement options capable of growth and self-repair for children born with congenital valve disease, for whom the current standard of care is multiple open-heart surgeries throughout their lifetime to repair or replace structurally-degraded valve prostheses. Allogenic valve transplantation has recently emerged as a means of delivering living and growing valve replacements, but its widespread adoption is restricted by the limited ex vivo viability of valve tissue and by concerns of transplant immunogenicity. This proposal aims to overcome these limitations by (i) developing a strategy for the ex vivo storage, preservation and immunologic rehabilitation of living valvular tissue, and (ii) evaluating the stored valve's viability, growth, and immunogenicity in a large animal model, thereby enabling storage, preservation and off-the-shelf availability of living valves, while simultaneously informing clinical immunosuppression regimens for allogenic valve transplantation in children with congenital heart disease.